Novel imaging-based platform for cell quality and identity control

Project Summary
Cell-based manufacturing and therapies, including those using human-induced pluripotent stem
cells (hiPSCs), require careful maintenance and tight control of the identity of cells in the culture.
The existing inexpensive cell identity tests typically rely on bulk analysis that does not reveal
cell-to-cell variability or the potential presence of distinct subpopulations. On the other hand,
single-cell analysis techniques tend to be expensive and complex and require a long turnaround
time, often prohibiting routine monitoring of cell identity. The goal of this project is to develop an
affordable platform for rapid analysis of hiPSCs identity on a single-cell level. The proposed
platform is based on the technologies of microscopic imaging of epigenetic landscape with
advanced image analysis, picowell arrays, and fluidic devices that have been recently
developed by a team of investigators. The successful completion of the proposed project will
result in a new platform for imaging-based single-cell analysis of the identity of hiPCSs with a
high resolution, lower cost per sample, and a much shorter turnaround time as compared with
the solutions currently available on the market. With some customization, the proposed platform
will also be applicable to single-cell identity tests of many other types of cells, e.g., blood cells,
neurons, cardiomyocytes, etc., further enhancing the value of the proposed development.

Public health relevance
Project Narrative The proposed project will result in a user-friendly platform for rapid, low-cost, high-resolution epigenetic tests of identity of human induced pluripotent stem cells (hiPSCs) on a single-cell level. It will enable close monitoring and tight control of epigenetic states and cell identities of hiPSCs that are essential for clinical applications. The techniques and methods developed in the project and modified versions of the proposed platform will have applications for other single-cell assays, including tests of identity of other cell types.